Medical Genetics Research Fellowship Program

PROJECT SUMMARY
This is an application for continued support for years 41-45 of a postdoctoral training program in
medical genetics based in the Department of Molecular and Human Genetics (DMHG) at Baylor College of
Medicine (BCM). The DMHG is a bridging department with major clinical activities and strong programs in
basic, translational, and clinical research. It uniquely integrates many of the activities that are traditionally
found dispersed through many academic departments and centers at most US academic institutions into a
single department at BCM. The emphasis of this postdoctoral program is on medical and human genetics and
on molecular approaches. There are 90 training faculty, 69 with primary and 21 with secondary appointments
in the DMHG (up from 79 in the last renewal submission in 2012). As part of a transition plan in program
leadership in 2012, Dr. Lee, took over as the PI of this training grant in renewing it for the current funding cycle
(years 36-40) from Dr. Arthur L. Beaudet. In continuation of this transition, Dr. Lee was appointed Chairman of
DMHG in Dec 2014 after an international search. An ambitious strategic plan has been implemented over the
past two years that has further enhanced the training environment including new faculty recruitment,
development of new clinical training tracks, formation of a diagnostic laboratory joint venture, and development
of a virtual platform to facilitate patient engagement in clinical care, education, and research. However, the
core of the Department mission remains research spanning all areas of human and model organism genetics.
Trainees derive mainly from ACGME and ABMGG approved residency and fellowship programs. The primary
focus of the program is to attract highly qualified MD and MD/PhD trainees who seek an intensive and
substantial research experience. In the past four years of funding, 87.5% of slots were assigned to MD or
MD/PhD trainees. Powerful drivers of training include faculty integration at the Department, Center, and NIH
program levels and leading clinical implementation of innovative technologies including array comparative
genomic hybridization, whole exome sequencing, metabolomics, and cell free noninvasive prenatal gene
sequencing in this application. Our stellar alumni who now populate our and many other medical genetics
programs support the success of this central tenet. Major strengths of the training environment include a large
clinical genetics component; large, comprehensive, and sophisticated diagnostic laboratories; 170,000 square
feet of space for the department activities; strong institutional commitment; a genetic graduate student program
with relevant course work; ACGME and ABMGG-certified training programs; high national ranking of NIH
funding for genetics departments (1st); NIH Large Scale Sequencing Center; NIH Intellectual and
Developmental Disability Research Center; NIH Center for Mendelian Genomics; NIH Undiagnosed Diseases
Network (UDN) Clinical Site (CS), Sequencing Core (SC), and Model Organism Screening Center (MOSC);
and NIH Knockout Mouse Phenotyping Program (KOMP3).

Public health relevance
NARRATIVE This is a training grant that supports primarily MD and MD/PhD trainees enrolled in human and medical genetics training. It has a long tradition of training current and future leaders in medical genetics research.